WOMEN'S HEALTH NURSING RESEARCH TRAINING

[unreadable] DESCRIPTION (provided by applicant): Women's health research at the University of Washington School of Nursing has emphasized women's health-related experiences in relation to biobehavioral dimensions of health, their sociocultural environments, and therapeutic processes to assist women in promoting, maintaining, and regaining their health. The purpose of this training program is to support predoctoral and postdoctoral research training within nursing science for the study of women's health. The continuation and expansion of this training effort will emphasize 1) extending and integrating knowledge of biobehavioral and sociocultural dimensions of women's health, incorporating advances in knowledge of genetics and sex and gender differences in health, 2) expanding understanding of health disparities, their causes and means to close the gap, among vulnerable sub-populations of women, and 3) advancing interdisciplinary and collaborative efforts to test interventions to promote, maintain, and restore women's health. [unreadable] [unreadable]